COVID19: SARS-CoV-2 and ACE2 interaction in hypertension

The current COVID-19 pandemic is one of the most disruptive events in human history, caused by the SARS-
CoV-2 virus, member of the coronavirus family that uses angiotensin converting enzyme 2 (ACE2), a
transmembrane carboxypeptidase identified as a member of the renin-angiotensin system (RAS) as an entry
point to the cells. Clinical reports suggest that pre-existing conditions such as hypertension, diabetes and obesity
predispose to COVID-19 mortality. Considering that these co-morbidities are highly prevalent in Veterans and
active duty personnel, these populations are at high risk of infection by SARS-CoV-2. The role of the brain RAS
in the maintenance of normal blood pressure (BP) and in the neuro-cardiovascular dysregulation leading to
hypertension has been firmly established. In addition, anosmia (loss of smell) is an early symptom of COVID-19
suggesting the brain is a primary target for SARS-CoV-2 infection. For the treatment of hypertension, two of the
most popular drug choices are ACE inhibitors (ACEI) and angiotensin-II (Ang-II) type 1 receptor (AT1R) blockers
(ARB). None of these classes of drugs have a direct effect on ACE2 activity, but there is evidence indicating that
they may alter long-term ACE2 expression levels and subcellular localization, suggesting that patients taking
these medications may be subject to more severe infections with SARS-CoV-2. Thus, clear data on the
relationship between ACE2 plasma membrane levels, SARS-CoV-2 and co-expression of other RAS members
are required to promptly adapt the therapy in this subset of patients. Beyond establishing ACE2 as a critical
player in the prevention of neurogenic hypertension, our group was the first to report that Ang-II mediates ACE2
internalization and degradation via AT1R activation. Thus, the hypothesis of this proposal is that ACE2-AT1R
complexes enhance SARS-CoV-2 infection in hypertensive Veterans while RAS blockers prevent ACE2
internalization and coronavirus infection. Taking advantage of unique resources, including a humanized
transgenic mouse expressing human ACE2 constitutively, we will determine whether AT1R contribute to SARS-
CoV-2 infection and whether ACEI and ARB reduce the incidence of COVID-19.

Public health relevance
The SARS-CoV-2 coronavirus responsible for the COVID-19 pandemic gains entry into the cells following interaction with human angiotensin converting enzyme 2 (hACE2). Based on our preliminary results, ACE2 is internalized following interaction with the Angiotensin-II type 1 receptor which might contribute to the high rate of infection in hypertensive active duty personnel and Veterans. Targeting of this mechanism will be investigated both in vitro and in vivo in order to determine its contribution to SARS-CoV-2 infection and test therapeutic approaches for hypertensive Veterans and active duty personnel.